Downregulation of neutrophil extracellular traps by fibrous regeneration template design.

This application's overall objective is to understand the mechanisms of NETosis, the process of secreting
neutrophil extracellular traps (NETs), on fibrous templates and to apply this knowledge gained to engineer
novel fibrous templates focused on the attenuation of the degree of acute NETosis. This attenuation will
be critical to limit any restriction of marginal tissue integration during in situ regeneration. The central
hypothesis of this study is that fibrous templates can be engineered via architecture and therapeutic
compound release to attenuate the degree of NETosis by acutely interacting neutrophils. Aim 1 will utilize
near-field electrospinning (NFES) to fabricate precision, square-grid templates such that fiber diameter
and pore size are the independent variables (template architecture) tested in the role of stimulating in
vitro, acute, template-induced NETosis. Aim 2 will elucidate NETosis mechanisms induced by the
templates and develop fiber-based, compound releasing vehicles as a supplemental means to architecture
design to attenuate acute, template-induced NETosis and potentially minimize NET-induced fibrosis.
Finally, in Aim 3, we will determine the in vivo template invoked degree of neutrophil NETosis and thus
test whether the in vitro results are correlative in terms of the degree of NETosis-template attenuation in
a rat subcutaneous model, in vivo veritas, and if this translates to enhanced marginal tissue integration.
In summary, this study's expected outcome and innovation will elucidate the critical structural variables
and therapeutic compound delivery in the refinement of fibrous, polydioxanone templates to allow for
critical three-dimensional tissue integration, free from the impediment of acute, surface NETs. These
results are then expected to translate to various degrees to other polymeric, fibrous tissue template
compositions and designs to advance the field of template-induced tissue engineering and in situ
regeneration in the treatment options for a wide variety of disorders plaguing our society.

Public health relevance
The results of this study will be an understanding of the role of fibrous template architecture in regulating neutrophil extracellular traps (NETs). More critically, we will identify mechanisms involved with the secretion of NETs upon template interaction and develop fiber-drug releasing templates to downregulate the induced degree of NETs. Thus, gaining critical knowledge allows for designing the next generation of fibrous templates with improved tissue regeneration efficacy and minimal fibrosis.